Multiplexed Locus-Specific Hypermutation for Functional Characterization of the Coding and Noncoding Genome

SUMMARY
While laboratory directed evolution has become a workhorse for generating novel
therapeutics and synthetic biomolecules, few tools exist for directly evolving the endogenous
mammalian genome. Most tools have extremely broad or narrow targeting windows (e.g.,
alkylators that introduce mutations genome-wide2 or CRISPR base-editors that target narrow
windows of 4-10 nts3,4). To systematically evolve entire gene regulatory networks and query gene
functions with base-level resolution, we must develop targeted long-range approaches that can
quickly introduce variants in gene sets and in multiple regulatory elements that contribute to gene
expressions. Here, we will develop a novel platform for performing multiplexed locus-specific
hypermutation within the mammalian genome called helicase-assisted continuous evolution
(HACE). HACE utilizes a nick-directed helicase fused to a deaminase domain to perform
continuous mutagenesis in a large (>1000nt) genomic target. This helicase-deaminase fusion can
be directed to specific genomic regions of interest using a Cas9 nickase (nCas9) with loci-specific
sgRNAs. We will apply HACE to functionally characterize both non-coding regulatory elements,
as well as enable multiplexed probing of the MEK signaling pathway for small molecule
resistance.

Public health relevance
NARRATIVE The fundamental challenge in genomics is to understand the role of all 3 billion bases in the human genome, which will allow us to link genetic variations to gene regulation and functions. Here, we develop a new tool to change the rate of genetic variation within specific regions of the genome, and study the effects of those variants on gene regulation and function.